Integrating cancer genomics and spatial architecture of tumor infiltrating lymphocytes

ABSTRACT
Tumor infiltrating lymphocytes (TILs) are an important component of the immune cells that reside in the tumor
microenvironment (TME). The type and number of TILs in the TME have an impact on overall survival and are
an indicator of response to immunotherapy. Despite their importance as an indicator of a patient’s immune
response to cancer, there are multiple challenges for analyzing TILS from large population data sets involving
thousands of samples. There is a lack of methods that can automate an analysis of histopathologic images for
different features such as the spatial distribution of TILs, their topological interactions with their neighboring cells
in the TME and their association with specific clinical outcomes. Even more challenging is integrating TIL metrics
with cancer genomic data. Most other methods provide qualitive metrics of TILs and frequently rely on manual
inspection from pathologists – this approach lacks scalability and is subject to observer bias. To address these
challenges, we developed a computational framework that uses a deep learning model to identify multiple cell
types from histopathology images. The major innovation of our approach is molecular label transferring that
annotates tens of thousands of small areas extracted from histopathology images without manual inspections.
This approach is highly accurate, efficient, scalable and readily automated for the analysis of millions of images.
The objective of this project is to address a key challenge in the application of deep learning to
histopathological image: large number of labeled images as training data set. We have three specific aims to 1)
identify spatial quantification of TILs from over 10,000 histopathological images from the Cancer Genome Atlas
Project; 2) correlate TIL metrics with clonal tumor mutation burden (TMB); 3) determine association of TILs with
immune checkpoint blockade responses. This research is significant because our approach enables for a
comprehensive characterization of TILs from histopathological images at cellular level, using data that is
commonly accessible in clinical settings and can be readily integrated with cancer genomic data.

Public health relevance
NARRATIVE Cancer patients have immune cells that potentially can attack the tumor. Knowing if these immune cells are present around the tumor provides a way of predicting the patient’s prognosis – however, there are no standardized ways of determining this information from patient’s biopsies. Our project addresses this challenge through a new computational method that analyzes microscopic images of a patient’s cancer and characterize immune cells in much higher resolution compared to what is done by pathologists.